FORUM ON REGENERATIVE MEDICINE

The work of the forum engages a diverse set of stakeholders to explore:
existing and potential barriers to scientific and therapeutic advances;
the impact of current policies on the discovery, development, and translation of regenerative medicine therapies;
the challenges of identifying, validating, and bringing regenerative medicine applications to market;
and the ethical, legal, and social issues posed by regenerative medicine advances.
Forum activities—including public workshops, membership meetings, and other information-gathering activities—provide opportunities to discuss important questions and challenges in the field of regenerative medicine and foster the advancement of high-quality science toward safe and effective therapies for patients.